Ion Channel Regulation

The FASEB Science Research Conference on Ion Channel Regulation, scheduled for August 3-7, 2025, at the Wellsworth Hotel in Southbridge, MA, is a biennial event that has been held since 2003. This conference will be be the most significant ion channel meeting of 2025, bringing together global experts to present cutting-edge research and engage in interdisciplinary discussions. Ion channels, crucial membrane proteins representing 1- 2% of human genes, are essential for various cellular processes and are implicated in numerous diseases, making them important targets for current and future therapeutics. The conference, co-chaired by Drs. Rose Dixon and Jonathan Silva, will feature a keynote lecture by Dr. Jeanne Nerbonne, ten scientific sessions with 30 invited speakers, poster sessions, and 23 short talks dedicated to trainees and early-career researchers. The conference has three main aims: to disseminate the latest discoveries and facilitate cross-pollination of ideas across subfields, to develop multidisciplinary networks integrating various approaches, and to support and train the next generation of ion channel researchers. The intimate setting with 100-175 participants participating in scientific discourse in a venue where they will also enjoy meals and social gatherings allows for more organic and less daunting exchanges among attendees at all career stages. Special features include flash talks, a "trainee-first" question format, and breakout sessions for early-career professionals. The conference will feature accomplished invited speakers and discussion leaders selected for their scientific expertise and contributions to the field, as well as the most promising early-career researchers showcasing innovative work. By achieving these aims, the 2025 FASEB SRC on Ion Channel Regulation will significantly contribute to advancing the field, nurturing emerging talent, and fostering collaboration in the field of ion channel research.

Public health relevance
NARRATIVE The 11th FASEB Science Research Conference (SRC) on Ion Channel Regulation, scheduled for August 2025, aims to bring together leading experts and emerging researchers in the field for an intensive week of knowledge exchange and collaboration. This biennial event will showcase cutting-edge research on ion channels, crucial membrane proteins that regulate cellular processes and are implicated in various human diseases, making them important targets for therapeutic development. The conference's focus on fostering interdisciplinary dialogue, supporting early-career scientists, and promoting diversity within the research community underscores its commitment to advancing the field of ion channel regulation and paving the way for future breakthroughs in understanding and treating membrane excitability disorders such as epilepsy, arrhythmia, diabetes and pain.